Research Participation Program

The National Institute of Environmental Health Sciences (NIEHS) Research Participation Program will provide opportunities for postdoctoral fellows, postgraduate individuals (Master’s, bachelor’s, and associate degree recipients), students, faculty members, and visiting scientists to participate in programs, projects, and activities supportive of the NIEHS, or to receive financial support for campus-based academic studies (such as scholarships and fellowships) related to the NIEHS’s mission